The Center for Health Improvement of Minority Elderly

Project Summary Overall Component
UCLA Center for Health Improvement for Minority Elders (CHIME) proposes continuation of a research and
mentoring program initially funded in 2002, that will contribute to the reduction in health disparities for minority
elders by training minority faculty who will advance their careers by conducting minority aging research.
CHIME has 5 specific aims: 1) to develop the research infrastructure needed to improve the health of minority
elders through the development, implementation, and evaluation of community and health sytem interventions
designed to mitigate health disparities which incorporates two of NIA's areas of scientific focus: i) research
aimed at understanding and modifying organizational or individual behaviors associated with positive and
negative health outcomes in later life and ii) research on factors that affect population aging, as well as the
consequences of population aging; 2) to conduct rigorous analyses of existing data sets to identify community,
health system, and person level correlates of health disparities to inform the design of interventions or health
policies to mitigate health disparities; 3) to contribute to the development, evaluation, and dissemination of
measures that can be used to track health outcomes or measure critical social, behavioral, and economic
predictors of the health and the health-care of minority elders; 4) to build on CHIME’s 15 year track record of
successful academic advancement of minority faculty through mentorship and support of their conduct of
independent research on the health of minority elders; 5) to broaden both existing and new partnerships with
communities to expand the pool of potential minority research participants and the beneficiaries of the findings
from both the research conducted under the auspices of CHIME and other funded research. CHIME will
address these aims through activities that are organized in an Administration Core (AC), a Research Education
Component (REC), an Analysis Core (AnC), and a Community Liaison and Recruitment Core (CLRC). The AC
and REC in collaboration with the External Advisory Group will select pilot studies and organize the mentorship
of RCMAR Scientists, CLRC will assist with recruitment and AnC will provide highly innovative methodological
training for RCMAR Scientists.

Public health relevance
Project Narrative for the Overall Component This renewal application, if successful, will allow UCLA CHIME to continue contributing substantially to mitigating health disparities for minority elders by developing minority investigators and arming them with the needed research skills to develop, implement, and evaluate community and health system partnered interventions in communities with the greatest health needs.